The role of immune cells in Alzheimer's disease

The adaptive immune cells also play important role in proper function of the central neural system (CNS). However, their role in Alzheimer's disease (AD) remains poorly understood even though a risk for dementia and AD increases together with the dysregulation of immune cells in the elderly. Although our previous results suggest that that B cells can alleviate AD symptoms via generation of Ab plaque-neutralizing antibody (Olkhanud et al, Vaccine, 2011), here report that B cells can be pathogenic in 2 types of mice that develop AD in young and old age, 2xTgAD and 3xTgAD mice, respectively. The mice were crossed with B-cell deficient (BKO) mice to generate 2xTgAD/BKO and 3xTgAD/BKO mice. Our results reveal that the loss of B cells in these mice appears to alleviate AD. Compared to age/sex-matched B-cell sufficient littermates, 3xTgAD/BKO mice exhibit less anxiety and improved memory deficits. Despite high levels of APP production in neurons, 3xTgAD/BKO mice contain significantly fewer Ab-plaques in the brain subiculum than age-matched 3xTg-AD mice. The over activated microglia in 3xTgAD mice, another hallmark of AD pathology, is markedly reduced in age/sex-matched 3xTgAD/BKO mice. We confirmed these results by transiently depleting B cells in 3xTgAD mice, which ameliorates AD. Overall these results for the first time indicate a pathogenic role of B cells in AD. Overall, the study is progressing as planned. Our current aim is to elucidate the mechanism how B cells exacerbate AD in aging.Our preliminary results suggest that B cells appear to facilitate aging-associated onset of AD by targeting inflammatory immune cells and affecting Trp pathway.